Reconstituting human testicular germ cell neoplasia in situ (GCNIS) in vitro using iPSC-derived primordial germ cell-like cells (PGCLCs) and genetically engineered human testicular cancer cells

Testicular cancers (TCs) are most common malignancies in young adult men. Most TCs are Type 2 germ cell
tumors, which arise from primordial germ cells (PGCs) or prospermatogonia, and the initial steps of TC
carcinogenesis occur in prenatal testes. Germ Cell Neoplasia In Situ (GCNIS) are the common prenatally
formed precursors of all subtypes of TCs. GCNIS are found in seemingly disease-free testes at the time of
birth, and more than 90% of adult-onset TCs are associated with GCNIS located in non-malignant portions of
the affected testes. GCNIS are also found in adult testes harboring high TC risk such as cryptorchidism or
abnormal sexual differentiation. When GCNIS are found in non-cancerous testicular biopsy, ~50% cases
develop TC in five years. Despite the obvious importance in TC pathogenesis, our knowledge of GCNIS is still
very limited, due primarily to difficult access to live human GCNIS or the lack of adequate animal models or cell
culture surrogates. Taking advantage of the latest progress in human germ cell biology, this R21 project will
attempt to establish in vitro models recapitulating carcinogenic process of human GCNIS in the environment of
xenobiotic testicular organoid culture or transplantation. We will produce human PGC-like cells (PGCLCs) from
induced pluripotent stem cells (iPSCs) derived from TC patients. These PGCLCs or their precursor iPSCs will
be genetically engineered to recapitulate the GCNIS-associated genetic events – namely, loss-of-function
CHEK2 mutations, gain-of-function KIT mutations, deficiency of pro-apoptotic BAK1/BAX genes, and
tetraploidization as our Forward approach converting normal PGCLCs to GCNIS cells. On the other hand, as
our Reverse approach converting invasive TC cells to GCNIS cells, we will deplete amplified isochromosome
12p, which are found in practically all cases of TCs but only rarely in GCNIS, by CRISPR-aided targeted
chromosome elimination. The engineered human PGCLCs and TCs will be subjected to two approaches to
recapitulate GCNIS, which fill the lumen of seminiferous tubules without invading through its wall. Our Specific
Aim 1 will construct the xenogeneic reconstituted testis (xrTestis) organoid culture, which consists of human
germ cells and mouse embryonic gonadal somatic cells. In Specific Aim 2, the human PGCLCs/TC cells will be
transplanted into the lumen of seminiferous tubules of genetically sterile W/Wv mice by microinjection, followed
by explant culture of the mouse testes. We expect that successfully reconstituted human GCNIS will fill the
lumen of the tubules-like structures in xrTestis (Aim 1) mouse testicular seminiferous tubules (Aim 2),
expressing PGC/GCNIS markers OCT4 and NANOG. Immunofluorescence studies and single cell RNA-seq
will be used to examine the resemblance of the GCNIS models to in vivo GCNIS, PGCs, gonocytes, and TCs
as well as cultured PGCLCs, TC cells, and gonocyte-like cells emerged from PGCLCs. The unprecedented
models of human GCNIS will be useful for studying molecular mechanisms of TC carcinogenesis and
developing strategies for eradicating GCNIS or suppression of GCNIS progression to TC.

Public health relevance
Testicular cancer, the most common malignancy among young adult men, arise from germ cells via a precursor lesion formed in testes of fetuses before birth. If the precursor lesion, which is known as Germ Cell Neoplasia In Situ (GCNIS), is found in adult testes, nearly 50% of the cases will develop into fully malignant cancers. However, due to the difficulties to obtain live GCNIS tissues or cells as well as the lack of adequate animal models or cell culture surrogate, our knowledge on biological characteristics of GCNIS has been very limited. Taking advantage of the recent progress in cell culture generation of human germ cells from the induced pluripotent stem cells (iPS cells) and testicular cancer genetics, this R21 project will attempt to establish cell culture and/or mouse explant models of human GCNIS, which will be useful for studying mechanisms of testicular cancer formation as well as developing strategies to eradicate GCNIS or suppress its progression to cancer.